Molecular Mechanisms of Membrane Protein Misfolding and Quality Control in Cellular Proteostasis

Abstract.
Most biological processes require the production and degradation of cellular proteins. Maintaining a balanced
protein homeostasis (proteostasis) is therefore essential to cellular fitness. Furthermore, lapses in proteostasis
have been linked to the molecular basis of a wide variety of genetic diseases. Nevertheless, our understanding
of how the cell buffers adaptive swings in proteostasis and how this is perturbed by mutations remains
incomplete. This is especially true for integral membrane proteins (MPs), which account for a quarter of the
proteome and include most drug targets. The production of folded, functional, and properly localized MPs is both
inefficient and sensitive to the effects of mutations that promote misfolding. The net efficiency of this process is
established by the interactions that nascent MPs form with chaperones that mediate quality control. Most MPs
form interactions with an array of QC proteins in the endoplasmic reticulum (ER) that establish the balance
between the degradation of immature protein and the export of mature protein from the secretory pathway. We
recently demonstrated that this balance is highly sensitive to the propensity of nascent MPs to adopt alternative
topologies with respect to the membrane. We found that mutations that promote these defects impact MP
expression and ligand binding in a manner that shapes both MP evolution and the molecular basis of disease.
Furthermore, we also found that the mechanical forces generated by formation of alternative topologies can alter
the outcomes of ribosomal protein synthesis. However, it remains unclear how certain topologies are selectively
recognized by molecular chaperones and how these interactions ultimately shape MP biosynthesis and
degradation. In the following, we outline innovative approaches to identify specific conformational defects that
promote the interaction of nascent MPs with various molecular chaperones including the ER membrane protein
complex and calnexin- two mechanistically distinct intramembrane chaperones. By combining CRISPR with deep
mutational scanning (DMS), we will determine which classes of mutations and their associated conformational
defects promote interactions with these chaperones and how this ultimately shapes mutational tolerance.
Additionally, we will build on our recent discoveries to gain insights into how these cotranslational processes
impact the fidelity membrane protein biosynthesis itself. We describe the discovery of a novel ribosomal
frameshift site within the CFTR transcript and provide evidence suggesting this motif selectively terminates
translation of a common misfolded variant responsible for most cases of cystic fibrosis (ΔF508). These findings
point to a novel role of ribosomal frameshifting in the regulation of membrane protein homeostasis. We outline
ongoing efforts to identify factors that modulate this regulation and to discover and characterize comparable
motifs in other disease linked MPs including the voltage-gated potassium channel KCNQ1. Together, our findings
will provide mechanistic insights into the regulation of membrane protein biosynthesis and quality control as well
as how these constraints factor into the molecular basis of proteostatic diseases of MP misfolding.

Public health relevance
Project Narrative. Numerous genetic diseases are caused by the misfolding of integral membrane proteins, which is a process that remains poorly understood. Based on our recent identification of various classes of biosynthetic defects, we propose a series of innovative experiments to determine how mutations cause these defects, how they impact membrane protein translation, and how they remodel membrane protein quality control. Our results will provide adaptable new experimental tools and novel insights into the molecular basis of disease.